Administrative Core

The Administrative Core coordinates the scheduling of meetings and research symposia
involving the student and faculty participants and all planning arrangements. Regular
meetings and correspondences occur between Program Project investigators at
Vanderbilt University, OHSU, and the University of Minnesota. The purpose of these
interactions is to evaluate ongoing research results that impact future directions and
collaborations. At all three institutions there are numerous opportunities to exchange
data. All program participants are trained in responsible conduct of research issues as
offered at their respective institutions. The Core serves as the interface with the External
Advisory Board (EAB) for the P01. The External Advisory Board is composed of
internationally recognized scientists, who meet regularly with the PIs, evaluating
progress and providing advice with regard to future research directions. Periodic
meetings and correspondence will be held with the EAB to discuss scientific progress
and future directions. The Administrative Core has the responsibility of working with all
PPG-associated personnel with the following broad objectives: timely submission of
Progress Reports, fiscal oversight and reporting for each of the projects and cores, The
Core coordinates with the Vanderbilt University Office of Sponsored Research that
directly communicates with off-site subcontracts at OHSU and University of Minnesota.
A primary function will be to work with and assemble data and reports, including
preparation of annual technical progress reports associated with this P01.

Public health relevance
Narrative The Administrative Core coordinates the operation and integration of the overall program, which is located at three sites—Vanderbilt University, Oregon Health & Science University, and the University of Minnesota. It coordinates communication and meetings between the three sites, and periodic meetings with members of the External Advisory Panel. It is responsible for preparing all annual reports. !